THIS COST PLUS FIXED FEE TASK ORDER IS FOR COORDINATED FACILITIES REQUIREMENTS FOR FY22 FACILITIES BAS UPGRADE

The NCI Frederick Building Automation System (BAS) is a complex network of computers which control and monitor nearly all the NCI Frederick building systems, including air handlers, exhaust systems, chillers and heating systems. Failure of a component of the BAS can result in the failure of one of these critical building systems with subsequent impact to scientific research or animal health. Many of the BAS controllers are the original version, Micro-Smart Controllers (MSC) from the late 1990’s and early 2000’s. Advancements in technology have made the MSC system obsolete and antiquated. Replacement parts for the MSC system are no longer available nor is the software supported. Hardware is unavailable, creating risks to the BAS and the building systems it controls.